GOAT-mediated ghrelin deregulation and hippocampal pathology in Alzheimer's Disease

Project Summary:
Hippocampal lesions constitute a characteristic brain pathology underlying memory loss in both familial and
sporadic Alzheimer’s disease (AD). Ghrelin, a stomach-produced, acylated peptide hormone, is the endogenous
agonist of growth hormone secretagogue receptor (GHSR, also known as ghrelin receptor). In addition to the
importance of the ghrelin system to systemic energy homeostasis, ghrelin passes the blood-brain-barrier (BBB)
to elicit hippocampal GHSR signaling for the modulation of hippocampal synaptic activity. In our last funding
period, we have determined the contribution of amyloid beta (Aβ)-induced GHSR deactivation to the
development of hippocampal synaptic failure and cognitive deficits in AD-related conditions. Interestingly, in
contrast to decreased availability of functional hippocampal GHSR, we also observed a paradoxical increase in
circulating bioactive ghrelin in both AD patients and mouse models, including a mouse model of familial AD
(5xFAD mice) and a mouse model of AD risk [human Aβ knockin (hAβ KI) mice, also referred to in the literature
as a mouse model of late-onset sporadic AD], indicating that ghrelin overactivation is a phenotypic change in
AD-relevant pathological settings. Although ghrelin is a neurotrophic peptide that stimulates GHSR to benefit
hippocampal synaptic activity, administration of a synthetic ghrelin mimetic demonstrated no protection of
cognitive function in 5xFAD mice and increased mouse mortality, echoing a previous failed large-scale clinical
trial. Importantly, further experiments showed that persistent ghrelin exposure induced dose-dependent GHSR
desensitization by promoting GHSR internalization. Together with the well-characterized detrimental impact of
ghrelin deficiency on cognition, these findings highlight the importance of normal ghrelin regulation to GHSR
function in hippocampal physiology and further implicate that disrupted ghrelin homeostasis due to overactivation
is an undesirable pathological event promoting hippocampal GHSR dysfunction in AD paradigms. Ghrelin O-
acyltransferase (GOAT) is the key enzyme that catalyzes ghrelin activation via acylation. Not only is GOAT
abundant within stomach ghrelin cells, but emerging evidence also suggests a role of plasma GOAT in the
maintenance of ghrelin activity in circulation. Other emerging evidence suggests that Aβ-induced GOAT
hyperactivity may be a key factor driving ghrelin overactivation in AD-related conditions. These observations,
together with the importance of ghrelin to metabolism, lead us to hypothesize that ghrelin overactivation due to
GOAT hyperactivity contributes to hippocampal deficits, leading to memory loss in AD. In the proposed study,
we will establish a link between GOAT hyperactivity, ghrelin overactivation, and hippocampal GHSR dysfunction
(Aim1), examine the impact of GOAT/ghrelin deregulation on hippocampal metabolism (Aim2), and determine
the contribution of GOAT/ghrelin deregulation to hippocampal synaptic injury and cognitive impairment in familial
and sporadic AD-related conditions (Aim3). The results from this study will answer important questions about
the ghrelin system in AD pathogenesis, and will suggest a novel avenue for the treatment and prevention of AD.

Public health relevance
Project Narrative This project is generated from our previous findings in the last funding cycle and aims to address a critical scientific question about the role of ghrelin system deregulation in the pathogenesis of Alzheimer’s disease (AD). Our studies will help to elucidate the impact of ghrelin O-acyltransferase (GOAT)/ghrelin deregulation on the development of hippocampal deficits and cognitive impairment in familial AD-, late onset AD-, and brain aging- related conditions. The results will provide a novel strategy for the treatment and prevention of AD and will impact our understanding of brain pathology in AD-related dementias such as age-associated cognitive decline (AACD) and Lewy body dementia (LBD).